Improving smoking cessation outcomes in the African American community through extended treatment: Addressing social vulnerability to advance treatment of menthol users

PROJECT SUMMARY / ABSTRACT
African Americans remain disproportionately burdened by tobacco, experiencing among the highest rates of
tobacco-attributable disease. Approximately 85% of African American adults who smoke use menthol
cigarettes. Which contribute to persistent tobacco use. African Americans and many groups of menthol users
experience excessive socioeconomic disadvantage; individuals with socioeconomic disadvantage are at
greater risk for smoking and less likely to stop. Addressing unmet social needs may offer a critical inroad to
supporting smoking abstinence. Evidence suggests addressing unmet needs can improve healthcare
outcomes, yet the impact of addressing unmet social needs within the context of tobacco treatment has not
been established. This revision application will exist within our ongoing parent study, the Kick It at Swope (KIS-
V) clinical trial, evaluating extended pharmacotherapy in 500 African American daily smokers (expecting 425
menthol and 75 non-menthol users), with the goal of increasing treatment efficacy. The objective of this
revision application is to characterize unmet social needs of African American menthol users by assessing
community-level neighborhood disadvantage and individual-level social needs and persistence or resolution of
those needs among 300 participants (255 menthol, 55 non-menthol), estimating over 200 enrolled prior to the
start of this revision and 100 enrolled within the first five months of this award. Our specific aims are to
evaluate individual-level social vulnerability and community-level social disadvantage among African American
menthol smokers, and to assess and describe the resolution of participant needs during the 6 months of
tobacco use treatment. These aims will be completed during the one-year of this award. The infrastructure put
in place will further support the long-term aim of evaluating community-level disadvantage, individual
vulnerability and social need, and resolution of needs in relation to smoking abstinence following treatment
following completion of the parent trial. Importantly, these findings from one of the largest samples of menthol
smokers within a clinical trial will produce strong evidence to inform individual- and system-level approaches to
enhancing treatment of menthol smokers. Findings will advance our understanding of the interrelationship of
key socioecological factors to smoking abstinence within treatment and will inform intervention for
socioeconomically disadvantaged smokers. Supporting long-term abstinence would have major impact on
reducing tobacco-related disparities, morbidity, and mortality.

Public health relevance
PROJECT NARRATIVE African Americans experience among the highest levels of tobacco-related disease and socioeconomic disadvantage; approximately 85% of African Americans who smoke use menthol, which contributes to persistent tobacco use. This study will characterize unmet social needs of African American menthol users by assessing community- and individual-level disadvantage, and will subsequently examine these key factors in relation to smoking treatment outcomes, with the goal of identifying opportunities to address needs and enhance treatment. Improving treatment for African Americans, including menthol users, is central to reducing disease burden and enhancing health equity.